Role of Cyclic Nucleotide Signaling in Age-related Decline of Social Memories

PROJECT SUMMARY: Compartmentalization of Cyclic Nucleotide Signaling in the Ventral
Hippocampus
After the age of 60, nearly all individuals experience some form of cognitive decline—particularly memory
deficits—and no drugs are able to prevent or reverse this loss. Age-related cognitive impairment, even in
absence of dementia, increases health care costs and risk for disability. Cognitive decline is not a uniform
process, with variability in symptom severity observed across individuals and across cognitive domains.
Associative long-term memories (aLTMs)—particularly those involving experiences with family and friends—
are more susceptible to age-related cognitive decline than are recognition long-term memories (rLTMs) for
reasons that are not well understood. The lack of knowledge of the molecular mechanisms that govern age-
related decline slows the development of novel therapeutics.
Phosphodiesterase 11A (PDE11A) is an enzyme that breaks down cAMP and cGMP, and PDE11A
may be an important molecular mechanism for regulating social aLTMs. PDE11A is almost exclusively
expressed in a small area of the brain called the ventral hippocampus, which is a brain region that is required
for the proper storage of social aLTMs. We have shown that hippocampal PDE11A4 expression dramatically
increases across the lifespan in mice, rats, and humans. This raises the question of whether this age-related
increase reflects a breakdown in physiological control of the hippocampus or an attempt of the brain to protect
itself. In preliminary studies, we have shown that mice that lack or express very little PDE11A are completely
protected against age-related cognitive decline of social aLTMs. Based on these and other preliminary studies,
we hypothesize that age-related increases in hippocampal PDE11A4 occur in a subcellular
compartment-specific manner and impair social aLTM. Across the 3 aims, we take an integrative
experimental approach by coupling in vivo genetic manipulations with in vivo behavioral tests as well as ex vivo
molecular and biochemical endpoints. In Specific Aim 1, we will determine if preventing or reversing age-
related increases in PDE11A4 can rescue age-related impairments in social aLTMs. In Specific Aim 2, we will
identify the circuit, cell type, and subcellular compartment where age-related increases in PDE11A4 expression
occur and identify the posttranslational modifications that drive these compartment-specific effects. In Specific
Aim 3, we will define the signals that drive age-related increases in PDE11A4 expression. These innovative
studies will provide much needed insight into the fundamental mechanisms of social memory as well
as the function and regulation of PDE11A in the brain. Targeting PDE11A may be a way to selectively
restore cyclic nucleotide signaling in a specific brain region that regulates social memories, without
affecting signaling elsewhere. This may relieve social deficits without causing unwanted side effects.

Public health relevance
Project Narrative/Public Health Relevance: Age-related cognitive decline, even in absence of full blown dementia, takes a devastating toll. Currently, there are no medicines that treat these symptoms. This proposal seeks to better understand how altered compartmentalization of cyclic nucleotide signaling in the hippocampal formation leads to age-related cognitive decline of social memories with the goal of identifying new therapeutic targets.